Hybrid surgical stapler with tissue sensing technology

PROJECT SUMMARY
Surgical staplers are important tools in modern-day surgery to perform sutures. Surgical staplers ensure
greater efficiency, sterility, and are easier to use. They also significantly reduce the chances of infection.
Modern specimens of the surgical stapler are equipped with various functional features and ergonomic
designs for to enhance durability and minimize complications. However, there are several reports on the
adverse effects and post-surgical complications associated with these devices. Patient injuries and
manufacturing defects have led to the recall of over 3.4 million surgical staplers, staples, cartridges and
components between 2013 and 2019 by leading manufacturers. Moreover, most of these devices are single
equipment thus adding to the bulk of electronic waste. Hence, a surgical stapling device equipped with
advanced engineering technology accompanied with ergonomic design and re-usability is a clinical
requirement.
RevMedica is developing Cybernetic, an innovative surgical stapler. Cybernetic is the first semi-reusable
stapler with a tissue recognition mechanism. It allows automated firing through tactile sensor-based
automated control unit. It can provide real-time feedback to the surgeon regarding the tissue thickness and
optimal firing parameters, thus improving the performance of a surgeon, while decreasing the risks like
misfiring and other complications. Cybernetic is economical, reduces downtime between surgeries, and
substantially reduces toxic waste from healthcare facilities. Through this Small Business Innovation Research
Phase I project RevMedica’s seeks to develop a prototype of surgical stapler: Cybernetic with a tissue-
sensing mechanism and enhanced functional features and establish its efficacy and safety in benchtop and
acute animal studies. The fundamental objectives in this Phase I project will be: 1) Development of the
hardware components of the system and benchtop validation. 2) In vivo safety and efficacy testing of the
prototype in acute animal studies. The proposed activities will allow the development and preliminary
validation of the prototype. The successful implementation of the Phase I project will pave the way for further
development of additional components and chronic animal studies for Phase II. In Phase II, further pre-clinical
studies will be performed to enable FDA regulatory approval.

Public health relevance
PROJECT NARRATIVE Malfunctioning of surgical stapling device leading to surgical complications and in few cases to death, is a major cause of concern for their use. RevMedica’s surgical stapling device Cybernetic performs real-time tactile clamping with tissue sensing technology, uses a force sensor and radio frequency identification (RFID) tags to determine optimal stapling parameters. It will decrease the degree of subjective decisions made while suturing and thus will enhance surgeon’s performance